Immunosuppression and Metabolic Rewiring in Tumor-infiltrating Neutrophils

PROJECT SUMMARY/ABSTRACT
Metastatic breast cancer (BC) remains largely resistant to immune checkpoint blockade (ICB) therapy.
Tumor-infiltrating neutrophils (TINs) with immunosuppressive activity represent a major component in the tumor
microenvironment (TME) to drive immunotherapy resistance. Therapeutic debilitation of immunosuppressive
TINs is a promising approach to elicit synergistic efficacy when combined with immunotherapy. However,
therapeutic targeting of TINs faces challenges in selectivity and safety, highlighted by the lack of TIN-specific
targets. Recently, we used single-cell RNA sequencing to compare TINs and circulating neutrophils in BC models
and identified aconitate decarboxylase 1 (Acod1) to be uniquely upregulated in TINs. Acod1 catalyzes the
production of itaconate, a metabolite with anti-inflammatory activity in macrophages. But Acod1 function in
neutrophils is poorly defined. Our preliminary results in BC mouse models suggest that TINs rely on Acod1 to
sustain survival in the TME, and Acod1 loss leads to reduced TIN infiltration and metastasis. There are still
significant knowledge gaps about the function, mechanism and therapeutic potential of Acod1 in TINs.
Our central hypothesis is that Acod1 upregulated in TINs that infiltrate metastatic BC is essential for the
TINs to persist in the TME and exert the immunosuppressive function, thus Acod1 ablation debilitates TINs,
favors anti-tumor immunity, and sensitizes metastatic BC to immunotherapy. We propose to accomplish three
Specific Aims: (Aim 1) Validate the pro-metastasis function of Acod1 in TINs in syngeneic and spontaneous
murine mammary tumor models. (Aim 2) Identify the upstream and downstream molecular mechanisms
underlying the upregulation and function of Acod1 in TINs. (Aim 3) Improve metastatic BC response to
immunotherapy by Acod1 ablation and validate ACOD1 expression in clinical samples.
To achieve our research goals, we have developed both whole-body and neutrophil-specific Acod1
knockout mice as hosts for BC syngeneic models, both mouse and human in vitro cell models of TINs, single-
cell technologies for gene profiling and immune cell phenotyping, injection techniques that generate mammary
tumors and metastases to lung and bone in the mice, and multiplex immunofluorescence staining techniques
suitable for validation studies using clinical samples. We have assembled a strong research team with
complementary expertise, which further ensures that the studies proposed are highly feasible to accomplish.
Upon completion of the project, we expect to uncover the previous unknown function and mechanism of
Acod1 in immunosuppressive TINs that are enriched in BC metastases, provide novel links between metabolic
rewiring and immunoregulatory function of TINs, and generate the key preclinical evidence for targeting Acod1
to improve immunotherapy. In the long term, we envision that the bench-to-bedside translation of our findings
through development of Acod1 inhibitors may accelerate the therapeutic application of combining agents that
reprogram immunometabolism and immunotherapeutics to the curative treatment of BC and other cancers.

Public health relevance
PROJECT NARRATIVE The majority of patients with metastatic breast cancer do not respond to immunotherapy with the tumor- infiltrating neutrophils as a major factor to mediate the immunotherapy resistance. Our preliminary results identify the metabolic enzyme aconitate decarboxylase (ACOD1) to be dramatically upregulated and functionally critical in tumor-infiltrating neutrophils. Upon completion of our project, we expect to define the mechanisms underlying neutrophil ACOD1 function in breast cancer metastasis and demonstrate the potential of ACOD1 inhibition to enhance metastatic breast cancer response to immunotherapy.